Brain Function and Neurogenomic influences on AUD risk and resilience.

This COGA (Collaborative Study on the Genetics of Alcoholism) spinoff application aims to understand
structural/functional features in key brain networks (Default Mode Network (DMN), Executive Control Network
(ECN), Reward/Salience Network (RSN)) underlying the critical transition from regular drinking to DSM-5
Alcohol Use Disorder (AUD) in young adult offspring from enriched COGA families, by combining newly
ascertained structural, diffusion and functional (s/d/fMRI), Neuropsychological (NPsych) and Electrophysiological
(EPhys) data together with existing multimodal longitudinal data (85% with 3+ assessments). The well-
characterized, genetically informative COGA sample with many offspring from families densely affected with AUD
at higher risk to develop AUD will be moving through the understudied age of young adulthood/early midlife (20's,
30's), when most longitudinal AUD development studies end and when our data predicts that a substantial portion
from high density families will transition from regular alcohol use to AUD. This proposal will target 150 young
adults (mean age 26) from the COGA study who are current regular drinkers (1/month+ for >6 months, but do
not currently meet criteria for DSM-5 AUD), and will follow them longitudinally with a multimodal approach to
compare those who transition to DSM-5 AUD and those who do not. We will add s/d/fMRI measures that are not
part of the COGA protocol, to provide anatomical specificity to complement current and existing NPsych and
EPhys longitudinal data during resting state, and three analogous cognitive/affective tasks [response inhibition
(Go/NoGo), reward processing (monetary gambling task), and affect modulation (cognitive/affective Stroop)].
Combining machine learning methods, advanced nonparametric, linear mixed methods, survival model, and joint
models of longitudinal data and survival data, we will: (Aim 1) identify features in specific neural circuits (DMN,
ECN, RSN) during resting state and during cognitive/affective tasks in young adults who transition from regular
drinking to AUD diagnosis from those who do not; (Aim 2) study the effects of drinking behaviors (e.g. age,
pattern, duration of alcohol use) on the s/d/fMRI, EPhys, and NPsych features in specific neural circuits
associated with the transition to AUD identified in Aim 1; and (Aim 3) determine the role of polygenic risk as
measured by polygenic risk score (PRS) derived from alcohol use- and brain-related GWAS, other risk/protective
factors [i.e., sex, race/ethnicity, family history, comorbid substance use (nicotine, cannabis), and psychiatric
disorders (depression), COVID-related traumatic stress] on neural circuits and their developmental trajectories
associated with transitions to AUD identified in Aims 1 and 2. The strength of our diverse, genetically informative,
enriched high-risk sample of young adults, longitudinal multimodal measures, and novel integrative analyses
will elucidate vulnerabilities and reciprocal relationships among neural circuits, genomic and other
risk/protectives factors in the transition to AUD during the 20s and 30s, with utility in prevention and treatment
initiatives.

Public health relevance
This project will address important challenges of understanding deficits in structural and functional brain networks underlying the transition from regular drinking to Alcohol Use Disorder (AUD) by investigating multidomain measures of brain function—structural/density-weighted/functional Magnetic Resonance Imaging (s/d/fMRI) longitudinal electrophysiological (EEG, Event Related Potential/Oscillation (ERP/ERO)) and neurocognitive data in a genetically informative enriched high risk diverse adolescent and young adult prospective study sample, now entering the understudied age of emerging adulthood to midlife. With the use of novel analytic methods to leverage this unique high risk longitudinal multimodal dataset, with data from before and after the initiation of drinking behaviors, this study will elucidate reciprocal relationships among genomic and other risk/protective factors (e.g., COVID-19 related traumatic stress), sex differences and the role of vulnerabilities in neural circuits in the transitions to AUD with utility in prevention and treatment initiatives.